Structural Robustness of Ribosome Functional Centers

DESCRIPTION (provided by applicant): The ribosome is the universal site of protein synthesis, containing some of the most highly conserved of all biological sequences. Nevertheless, the ribosome is robust to mutation, capable of functioning when challenged with base or amino acid substitutions in its highly conserved functional centers. As major targets of antibiotics, these functional centers are the sites of numerous antibiotic-resistance mutations. While it has been well established that antibiotic-Resistance mutations carry a substantial fitness cost, the structural basis for this burden is only now within the scope of our technical ability to investigate. In this proposal, we describe a synthetic approach using genetics, chemical probing and X-ray crystallography of ribosomes from the thermophilic bacterium Thermus thermophilus to address the structural robustness of ribosome active sites and its relationship to biological fitness. Our development of T. thermophilus ribosome genetics has enabled us to identify or construct antibiotic-resistant mutants at will. We also now have the technical ability to crystallize wild-type and mutant 30S ribosomal subunits and 70S ribosomes and to determine their three-dimensional structures by X-ray diffraction. Together with the development of novel chemical probing techniques to investigate RNA conformational dynamics, these abilities have placed us in a unique position to address three specific issues. The first aim of our proposal is to use streptomycin-resistance mutations as a paradigm for examining the mutational robustness of a conserved ribosome functional center that participates in global conformational changes of the 30S subunit. Our second aim is to use tuberactinomycin-resistance to examine the effects of mutations on the structure and function of an intersubunit bridge that is critical for large-scale rotational motions of the entire 70S ribosome. The third aim is to use deleterious antibiotic-resistance mutations in the peptidyltransferase active site to evolve compensatory mutations that restore fitness, and to examine their structural effects using X-ray crystallography. The goal of this aim is to detect as yet unrecognized long-range functional relationships throughout the ribosome. We will also use the peptidyltransferase active site to examine the limits of robustness of ribosome functional centers to mutation. In addition to providing a more complete mechanistic understanding of antibiotic resistance at an unprecedented level of resolution, these efforts are directed towards establishing fundamental principles of ribosome structural organization and evolution.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this project is to study the impact of antibiotic-resistance mutations upon ribosome structure and function in order to gain a better understanding of the molecular mechanism of resistance. Results from these studies will provide valuable information for the rational development of new ribosome-targeting antibiotic compounds to combat pathogens that are resistant to currently available drugs. PROJECT NARRATIVE The goal of this project is to study the impact of antibiotic-resistance mutations upon ribosome structure and function in order to gain a better understanding of the molecular mechanism of resistance. Results from these studies will provide valuable information for the rational development of new ribosome-targeting antibiotic com- pounds to combat pathogens that are resistant to currently available drugs. __SpecificAimsTextDelimiter__ SECTION 2 SPECIFIC AIMS The ribosome is the universal site of protein synthesis, with multiple functional centers containing some of the most highly conserved base and amino acid sequences in biology. Despite this extreme level of conservation, many of these sites are robust to mutation, continuing to carry out protein synthesis. However, the extent to which ribosome structural integrity is a prerequisite for biological function is a parameter, which at present is poorly understood. While numerous mutations have been identified in ribosomal functional sites, very little information exists regarding the structural perturbations they cause, or the ribosome's ability to accommodate these changes into a functionally active structure. It is also not known to what extent a given mutation imposes a static, non-native conformation or increases local conformational dynamics. The goal of the work proposed here is to determine the basis of the relationship between mutational robustness and structural integrity using a combination of genetics, chemical probing and X-ray crystallography, and in so doing, to establish fundamental principles of ribosome structure, function and evolution. It has become increasingly clear that large-scale conformational changes in the ribosome are a central aspect of its function. The decoding center on the 30S subunit is the focal point of a global conformational change that occurs during tRNA selection. Similarly, the intersubunit bridge B2a is functionally critical for an intersubunit rotational motion of the 70S ribosome that occurs during translocation. Mutations or antibiotics binding to these region are either known or predicted to shift these conformational equilibria. How small local changes are propagated throughout the ribosome to influence such large-scale changes remains largely unclear. Thus these functional sites must also be sufficiently robust to mutation to permit the transmission of long-range conformational signals. Recent genetic studies indicate that previously unrecognized long-range functional relationships between seemingly unrelated functional centers may be revealed through the lab- oratory evolution of compensatory mutations that relieve the fitness costs of deleterious mutations. We are now in a position to address these questions having developed ribosomal genetics of Thermus thermophilus, and the ability to determine ribosome structures using X-ray crystallography. We are also continuing to develop chemical probing methods that will allow a more comprehensive structural analysis of ribosomal mutations. We propose to apply these methods to address the following specific aims. Specific Aim 1 Examine the structural robustness of a 30S subunit functional site. We will determine X- ray crystal structures of mutant 30S subunits to obtain high-resolution structural data to ascertain effects of streptomycin-resistance mutations in the decoding center on both local and global subunit conformation. We will complement these experiments with a variety of chemical probing techniques designed to assess changes in the structural dynamics of RNA. Specific Aim 2 Examine the structural robustness of an rRNA intersubunit bridge critical for conformational dynamics of the 70S ribosome. We will solve X-ray crystal structures of mutant 70S ribosomes containing base substitutions and deletions in the intersubunit bridge B2a. We will measure the effects of these mutations on the translocation step of protein synthesis in vitro, and use chemical footprinting to determine the effects of mutations on the formation of hybrid tRNA binding states, a key intermediate in translocation. Specific Aim 3 Identify novel, cooperative, functional relationships within the ribosome using compensatory evolution. Starting with mutants of T. thermophilus having deleterious base substitutions in the peptidyltransferase active site, we will evolve compensatory mutations that restore fitness. We will determine sites of compensatory mutations using gene sequencing and mass spectrometry techniques. Mutants will be functionally characterized using in vitro protein synthesis assays and selected mutants will be examined structurally by X-ray crystallography and chemical probing. Finally, we will use the peptidyltransferase active site to explore the upper limit of mutational robustness of a ribosome functional center.